Project 1 - Defining the structure and function of NTS satiety circuits

Abstract Project 1- Project 1: Defining the structure and function of NTS satiety circuits
While much recent energy balance-directed research has focused upon hypothalamic
circuits, these hypothalamic systems largely mediate their effects on feeding via hindbrain circuits.
Furthermore, many of the most effective pharmacological obesity treatments act on brainstem
satiety systems. The inadvertent production of aversive symptoms such as nausea, which is
mediated by circuits that are intermingled with brainstem satiety systems, represents one of the
most important limitations to therapies that target these systems, however. Thus, it will be crucial
to distinguish the brainstem circuits that encode satiety from those that promote nausea and other
aversive symptoms, since the non-aversive circuits represent ideal targets for therapy.
This project will define the neural circuits by which the NTS controls feeding and by which
it signals aversive or non-aversive responses, as appropriate for the stimulus. In addition to
enhancing our understanding of neural systems important for the control of ingestive behavior,
distinguishing non-aversive from aversive satiety systems may permit the design of improved
therapies to decrease food intake and combat obesity.

Public health relevance
Narrative This project will define the neural circuits by which the NTS integrates and transmits gut signals to control feeding with the appropriate valence for the stimulus. In addition to enhancing our understanding of neural systems important for the control of ingestive behavior, disentangling the neural systems that encode satiety and positive valence from those that mediate anorexia with negative valence may permit the design of improved therapies to decrease food intake and combat obesity.